The role of ceramide kinase in mitophagy

Ceramide-1-phosphate (C1P) is produced via the phosphorylation of ceramide by ceramide kinase (CERK).
Although C1P has been implicated in key aspects of inflammatory responses and wound healing, this bioactive
sphingolipid still remains understudied and little is known about the regulation of CERK. Indeed, the activation
of CERK (50-fold) by cardiolipin (CL) has been overlooked as well as the enzyme’s location at the outer
mitochondrial membrane (OMM). As damaging events move CL from the inner mitochondrial membrane (IMM)
to the OMM, we examined whether CERK acts as a biosensor of CL-dependent mitochondrial damage via
producing C1P. In preliminary studies, we found that mitochondrial damage induces mitochondrial C1P levels.
Genetic manipulations that inactivate CERK expression block this effect as well as enhanced cell death. We also
identified a possible CL-binding site in CERK, and a structurally intact, CL-binding deficient mutant of CERK
demonstrated deficiency in CL association/activation. In response to mitochondrial stress agents, re-expression
of this CERK mutant failed to “rescue” mitochondrial C1P generation and resistance to cell death in CERK-/- cells
in contrast to wild-type (WT) CERK. Thus, we hypothesize that CERK acts as a sensor for mitochondrial
damage via its CL-binding domain to induce C1P, thereby, reducing ceramide levels to mitigate intrinsic
apoptosis/cell death that can be triggered by elevated ceramide levels in the OMM.
We further propose that CERK acts as a rheostat for cell survival by signaling the induction of mitophagy, a
specific autophagic degradation process for clearing damaged mitochondria. Our preliminary data show that the
genetic removal of CERK blocks mitophagy. We, thus, hypothesize that CERK plays a major role in stimulating
mitophagy and mitigating cell death by utilizing mitochondrial ceramide to generate C1P.
UVRAG, a key initiation factor for autophagy induction, reportedly suppresses apoptosis by regulating BAX
association with the mitochondria. Our preliminary studies show that UVRAG specifically interacts with C1P.
Moreover, the interaction of UVRAG with cellular membranes was dramatically decreased in CERK-/- cells in
response to mitophagic stimuli. Thus, we further hypothesize that CERK regulates mitophagy and cell survival
via the generation of C1P and subsequent recruitment of UVRAG to the OMM. To validate our hypotheses, we
propose three specific aims to determine the role of CERK as a cellular “rheostat” and driver of mitophagy. We
also propose to identify key C1P-sensors (e.g., UVRAG) in cells that mediate these biological mechanisms.
Significance: These studies have the potential to delineate a new signaling paradigm in mitophagy and cell
survival with implications in cancer therapeutics, cardiac pathophysiologies, and neurodegenerative diseases.

Public health relevance
In the proposed study, the role of the protein, ceramide kinase, is being examined in relation to a key cellular process regulating the survival of cells. These studies have the potential to delineate a new signaling paradigm in regulating cell fate with implications in cancer therapeutics, cardiac pathophysiologies, and neurodegenerative diseases.